The Regulation of Lens Fiber Cell Differentiation

Revised Abstract: The underlying pathology of cataract can often be demonstrated to involve defects in the differentiation of lens fiber cells from their proliferative transitional zone precursors. These studies seek to elucidate the mechanisms responsible for lens fiber cell differentiation by elucidating the mechanisms controlling the transcription of betaB1-crystallin, a gene expressed exclusively in differentiating lens fiber cells. Specific aim one seeks to determine the molecular mechanisms that allow betaB1-crystallin to be expressed at nearly 3% of total cellular mRNA in the lens. This study is likely to give insight into how the single copy crystallin genes can contribute to the high concentrations of protein seen in the lens. Specific aim two seeks to connect the observation that growth factor/receptor interactions control lens fiber cell differentiation to the transcriptional consequences of the signaling induced by these interactions. These investigations will allow us to connect growth factor signaling to the dramatic changes in gene expression coincident with the transition from an epithelial to a fiber cell. Specific aim three seeks to determine the molecular mechanisms responsible for the redistribution of Prox1 protein during lens differentiation. These studies are critical to the understanding of how Prox1, a protein essential for fiber cell differentiation, functions in the lens. These complementary studies should provide insight into how lens fiber cell differentiation is controlled and how this process is disrupted during cataract formation.